Interdisciplinary Training in Cancer, Caregiving and End-of-Life Care

Project Title: INTERDISCIPLINARY TRAINING IN CANCER, CAREGIVING AND END-OF-LIFE CARE
Primary Investigator: ELLINGTON, LEE A
Abstract: This renewal application for a successful T32 training grant awarded in 2013 has the goal of
educating and training nurses at the pre- and postdoctoral level to become leaders of interdisciplinary team
science in cancer, caregiving and end-of-life care. The three foci of our renewal application pose daunting
problems for health care and demand action from the next generation of scientists and clinicians to innovate
change across the care continuum for patients and families. We propose to build upon the strengths of the
current T32 to train a cadre of nurse investigators using a unique training delivery approach. The Utah Model
of live-interactive video distance education has been nationally recognized for innovation and educational
access and provides a successful and sustainable platform for our training program. In the current T32
program, we have demonstrated that we can successfully extend and expand the Utah Model from our well-
established PhD program to intensive postdoctoral research training. Our training program is uniquely
positioned to attract a strong and diverse pool of nurses who are unable to relocate but want to pursue an
investigative career in cancer, caregiving and end-of-life care. This T32 proposes to prepare eight predoctoral
and eight postdoctoral nurse scientist trainees over the next five years. Each trainee will participate in a two-
year training program consisting of a combination of mentored research and career development training,
seminars, journal club, intensives in innovation, trainee interest groups, visiting scholars, conference-based
learning, and course work. These nursing scientists will gain the knowledge, expertise, and leadership skills to
lead innovative programs of research that will ultimately affect individuals with cancer, other chronic or life-
limiting illnesses and their families. The renewal application focuses on training and research in the domains of
cancer, caregiving and end of life aligning with the National Institute of Nursing Research priorities for the
health of our nation. Program objectives are to: 1) engage trainees in state of the science knowledge and
stimulate innovative thinking that addresses key research questions in the three domains; 2) prepare trainees
to conduct research using rigorous methodological skills and sophisticated analytics to support innovative
designs that advance the science; 3) to provide trainees with the requisite skills and experiences in successful
grant writing, publications and presentations that lead to high impact dissemination, translation, and
implementation of research findings to improve clinical practice and community health; and 4) mentor trainees
to become leaders of interdisciplinary science teams and influencers of research and health policy in cancer,
caregiving, and end-of-life care.

Public health relevance
Public Health Relevance Statement The number of patients with chronic and life-limiting illnesses, like cancer, and their family caregivers are increasing, and their health and psychosocial needs are having a profound impact on health services. There is a need for the next generation of scientists to provide evidence on how to best help patients and families sustain health and well-being, foster patient and family engagement, manage symptoms associated with chronic disease and die free of pain and family burden.